Intermittent Hypoxia Initiated Motor Plasticity in Individuals with Multiple Sclerosis

PROJECT SUMMARY/ABSTRACT
Multiple sclerosis (MS) is an immune-mediated neurodegenerative disease of the central nervous system that
causes localized damage to myelin, resulting in loss of function, disability, and reduced quality of life. Although
disease-modifying drugs can help reduce the frequency of relapses and onset of new symptoms, this approach
is insufficient for optimal recovery from existing symptoms. One potential approach to overcome functional
impairments related to existing motor deficits is through development of therapeutic strategies that induce
neuroplasticity. The objective of this proposal is to investigate the potential of a novel therapeutic intervention —
Acute Intermittent Hypoxia (AIH) — that has shown significant promise to enhance neuroplasticity in persons
with spinal cord injury but has not yet been studied in MS. AIH constitutes a brief, repeated reduction in oxygen
concentration which stimulates the serotonergic pathway and enhances activity of serotonin receptors. This
results in increased synthesis of plasticity-related proteins that potentiate synaptic transmission and drive
plasticity. We hypothesize that a repeated AIH protocol will improve voluntary limb function in individuals with
MS. We also hypothesize that AIH will induce sustained changes in neural activity within the central nervous
system, which contribute to therapeutic plasticity. We test this hypothesis using a double-blind, sham-controlled
and crossover trial in MS patients with established motor deficits and controlled relapse activity who are
administered mild doses of intermittent hypoxia (or sham hypoxia) for five days. We examine the resulting effects
by quantifying changes in strength, function and walking performance immediately and 1-week post-intervention.
We also use advanced functional magnetic resonance imaging techniques to measure changes in neural
activation during voluntary ankle flexion and intrinsic connectivity in the somatomotor cortices at rest, which have
both shown plasticity-related changes during successful motor rehabilitation strategies. Additional clinical MRI
scans at enrollment and 1-week post-intervention will be monitored for radiologic signs of new disease activity
as part of participant safety monitoring. This proposal will determine the extent to which priming the central
nervous system with an approach known to induce plasticity improves function in MS, and provide evidence of
the neural mechanisms driving these therapeutic effects. The insights gained from this work will inform the
development of more effective therapies combining daily AIH with task specific training for improvement of
function and quality of life in individuals with MS.

Public health relevance
PROJECT NARRATIVE Although progression of Multiple Sclerosis (MS) can be radically slowed with newer medications, no treatment is available for alleviating existing motor deficits, which vastly affect the quality of life in people with MS. In this study, we examine an emerging therapy - acute intermittent hypoxia (AIH) - that strengthens neural circuits and ultimately enhances movement ability in spinal cord injury, and may have similar benefits in MS. The results of this project, which include measures of lower-limb function and brain imaging, will inform clinical researchers if this therapy is viable for treating MS symptoms.